SAFETY AND PHARMACOKINETICS OF INCREASING DOSES OF BMS 180194 IN HIV SUBJECTS

Assess the safety, tolerance, pharmacokinetics, andoral bioavailability of ascending doses of a new compound with in vitro activity against cytomegalovirus.